Studying the modulators and the physiological functions of RNA tailing in the C. elegans oocyte

ABSTRACT
The decreasing quality of oocytes, associated with maternal age, is a major component of
reduced fertility in older women. Many molecular markers are observed in deteriorating oocytes,
including transcriptomic changes. Interestingly, in most animal models, the end of oogenesis and
early embryogenesis proceed in the absence of transcription, relying on stored messenger RNAs
(mRNAs). The developing oocyte carefully manages different populations of RNA during
maturation, fertilization, and zygotic genome activation to successfully jumpstart embryogenesis.
The accumulation of these maternal transcripts during oogenesis is therefore essential. Yet we
know very little of how the transcriptome is sculpted after the transcriptional machinery is
inactivated. What drives transcriptomic changes and how are they contributing to oocyte quality?
RNA tailing, or the addition of untemplated nucleotides to the 3' end of RNA molecules, is a post-
transcriptional process that has long been associated with the regulation of RNA stability and
translation. Both nucleotide composition and length of tails can determine tail function. RNA tails
are especially dynamic in the germline and the early embryo. The objective of this work is to
identify the terminal nucleotidyl transferases and exonuclease that modulate RNA tails and to
elucidate the mechanism that mediate the downstream effects on RNA stability and translation in
the oocyte. First, I will examine the physiological function of TNTs and exonucleases in C. elegans
fertility. Second, I will characterize changes in RNA tail length and composition during oogenesis
and early embryogenesis to shed light on conserved pathways involved in generating viable and
competent oocytes. Third, I will identify the co-factors that act upstream and downstream of TNTs
and exonucleases, to coordinate their activity, and modulate tail-mediated regulation of RNA
stability and translation. I am uniquely qualified to conduct this research, having studied different
types of RNA and their biology throughout my graduate and postdoctoral training. In Katherine
McJunkin’s laboratory, I have used the C. elegans model system and large-scale genomic
screens to identify TNTs responsible for miRNA tailing and to assess its impact on microRNA
turnover. In the proposed work, I will apply state-of-the-art techniques to dissect the machinery
responsible for mRNA tailing in the context of reproduction and fertility. This work seeks to explore
post-transcriptional mechanisms regulating gene expression during the oocyte-to-embryo
transition and their contribution to oocyte quality.

Public health relevance
PROJECT NARRATIVE The principal goal of this project is to dissect and study the machinery that modulates RNA tailing and its effects on RNA stability and translation. These mechanisms will be explored during C. elegans oogenesis and early embryogenesis, taking advantage of the window of transcriptional inactivity when post-transcriptional regulation of gene expression is critical. In the process, this project will also identify essential genes for oogenesis and shed light on how their regulation is critical to their physiological function in the oocyte.